Educational-Clinical Linkage to Improve Health Equity for Children with Developmental Delays and Disabilities from Marginalized Communities

ABSTRACT
Societal and structural inequities have resulted in longstanding health care disparities among Black, Hispanic,
and low-income preschool-age children with developmental delays and disabilities (PCw/DD) depriving them of
educational and therapeutic services which foster development and improve later academic, economic, and
health outcomes. Studies also indicate when children receive these needed services, their parents benefit with
improvements in mental health, stress, and quality of life. The scientific objectives of this proposal are to 1) test
effective strategies to increase access to ECSE services among PCw/DD from historically marginalized
communities; and 2) characterize potential mechanisms by which such strategies may lead to improved
multilevel health outcomes. Preschool and Me (PreM) is a novel community clinical linkage (CCL) designed for
clinical settings serving historically marginalized communities. Combining key components of CCLs with a
personalized medical-education care plan and remote navigator support, PreM targets different levels of
influence impacting therapeutic access identified in our prior research. In pilot testing, PreM was feasible to
deliver, acceptable to parents, and demonstrated preliminary efficacy on completed ECSE evaluations among
families attending a pediatric clinic serving largely Black and Hispanic families from low-income communities.
Thus, this R01 application proposes to utilize a hybrid effectiveness-implementation approach to test PreM in
two models of real-world service delivery conditions. Participants (n=320) will be randomized to either: 1) 6
months of PreM (intervention group) or 2) a waitlist control arm beginning the intervention after a 6-month
delay. We will follow all participants for 12 months with data collection occurring at 4 timepoints (baseline, 3-,
6- and 12-months). Our specific aims are to test effectiveness of PreM on indicators of ECSE access (primary)
and child-, parent-, family- and health service outcomes (secondary); examine theoretically derived mediators
of intervention effects using a mixed methods approach; and explore social determinants of health as potential
moderators. We will also simultaneously conduct a mixed methods implementation evaluation focusing on
implementation outcomes to serve as indicators for implementation success; measures of implementation
quality; and intermediate outcomes to understand and address successes and failures in relation to clinical
outcomes. The results of this project have the potential to: 1) advance scientific knowledge about how gaps
and delays in educational and therapeutic services impact health outcomes among PCw/DD and their families;
2) identify mechanisms to increase access to ECSE services and address longstanding health care disparities;
and 3) support effective implementation of educational-clinical linkage models within pediatric clinical settings
serving historically marginalized communities which can be utilized to improve health outcomes for families
and their children with a range of health conditions.

Public health relevance
NARRATIVE We propose to test an innovative model connecting clinical settings serving historically marginalized communities with early childhood educational services for preschool-age children with developmental delays and disabilities. In doing so, our study aims to improve access to educational and therapeutic services which foster developmental skills and improve health outcomes for families and their children with developmental delays and disabilities.